Deciphering the role of FAM210A in cardiac physiopathology

Heart disease is the leading cause of morbidity and mortality worldwide. In healthy myocardium, the
mitochondria utilize oxidative phosphorylation to generate ATP and metabolites to support pumping
blood throughout the whole body. Given this critical function of mitochondria in the heart, mutations or
reductions of essential mitochondrial factors cause mitochondrial cardiomyopathy (MC) in humans and
mice. Mitochondrial dysfunction is also a major pathogenic driver in non-genetic ischemic heart disease
such as myocardial infarction (MI). Better understanding of mitochondrial protein functions and
pathogenic molecular mechanisms underlying mitochondrial dysfunction will promote the development of
therapeutics for MC or MI. Recent RNA-seq coupled with ribosome footprint-seq analyses in mouse
hearts reveal Fam210a (family with sequence similarity 210 member A) as a hub gene in cardiac
remodeling. Our preliminary data suggests reduced FAM210A expression in mouse MI hearts and
human ischemic heart failure. Cardiomyocyte (CM)-specific homozygous (Homo) conditional knockout
(cKO) of Fam210a in adult mice led to MC and mortality. Interactome analyses reveal that FAM210A
binds to mitochondrial Ca2+/H+ exchanger LETM1 (Leucine zipper and EF-hand containing
transmembrane protein 1) and promotes mitochondrial Ca2+ (mCa2+) efflux in vitro and in vivo. Therefore,
Fam210a deletion in CMs resulted in an elevated mCa2+ and reactive oxygen species and compromised
mitochondrial membrane potential. As a result, the mitochondrial respiratory activity was reduced in
Fam210a KO CMs, leading to cardiac dysfunction at a late stage. In addition, persistently activated
integrated stress response (ISR) contributed to the disease progression in Fam210a cKO hearts.
Moreover, CM-specific heterozygous Fam210a cKO mice exhibited lower FAM210A protein expression
and more severe cardiac remodeling than control mice under MI. In contrast, AAV9-mediated
overexpression of FAM210A could protect hearts from MI-induced cardiac damage and dysfunction. Our
central hypothesis is: FAM210A functions as a mitochondrial Ca2+/H+ antiporter regulator and maintains
normal mitochondrial and cardiac function. We will test this hypothesis by pursuing 3 aims. Aim 1.
Decipher the molecular mechanism of FAM210A in regulating mCa2+ homeostasis. Aim 2. Elucidate the
role of FAM210A in regulating cardiac mitochondrial activity and cardiac function. Aim 3. Determine the
effects of FAM210A overexpression on the functional performance of mitochondria, CMs, and the heart
under MI. Collectively, our studies provide novel insights into the function and mechanisms of FAM210A
in regulating cardiac mitochondrial integrity and thus maintaining the normal physiological function of the
heart. This project also suggests that reduced FAM210A level contributes to the MI-induced cardiac
pathological remodeling and overexpression of FAM210A has a cardioprotective role in MI treatment.

Public health relevance
Project Narrative: Heart disease is the leading cause of morbidity and mortality in the United States and mitochondrial dysfunction is a major contributor in disease progression. Better understanding of the pathological mechanisms underlying mitochondrial dysfunction during heart disease will improve preventive and therapeutic interventions. In this proposal, we will investigate the function and mechanism of a novel mitochondrial Ca2+ signaling regulatory factor, namely, family with sequence similarity 210 member A (FAM210A), which is required for maintaining mitochondrial homeostasis and cardiac health. These studies will lead to identification of novel therapeutic targets for treatment of mitochondrial cardiomyopathy and ischemic heart failure such as myocardial infarction among other mitochondrial disorders.